Highly Integrated Nucleic-Acid Analysis Using Graphene Bioelectronics

PROJECT SUMMARY
The circulating population of microRNAs in biofluids are ideal biomarkers for various diseases. Point-of-care
profiling of circulating microRNAs is in insatiable demand, but typical approaches, e.g., immunoassays and
microRNA assays are lab-based/centralized, expensive ($400–1,000/test), and time-consuming (>6 hours). We
will develop a highly integrated, all-nanobioelectronic platform technology for multiplex, high-accuracy
circulating-microRNA analysis that is capable of profiling circulating microRNAs in a 50-μL plasma with ultra-
high sensitivity (sub-fM) and efficiencies in time (<40 minutes) and cost (<$10/test), thereby enabling high-
performance circulating-microRNA analysis at the point of test. The novelty of the program is to harness
graphene-based bioelectronics to integrate circulating microRNA isolation, concentration, amplification, and
quantification into a self-contained device. In order to proof the concept of this technology, the program will
include the development and validation of two generations of graphene-based analytical platforms, GAP1 and
GAP2. Three specific aims with measurable milestones will be pursued. (1) We will demonstrate that multiple
microRNA analytes can be amplified via hybridization chain reaction on a probe-functionalized graphene sensor
array and the analyte concentrations can be readily interrogated by the graphene sensor array and translated
into electrical signals. We will develop GAP1 to selectively quantify eight pre-selected target microRNAs
(MDCIS8) spiked in 5-μL buffer. The detection limit of the specific microRNAs is expected to be at fM level. (2)
We will demonstrate that target circulating microRNAs can be isolated from plasma by immobilizing them on a
DNA-functionalized graphene electrode and releasing them into a small-volume simple cargo solution upon the
generation of pH gradient by applying voltage bias between the graphene-DNA electrode with a bare graphene
electrode. We will develop a graphene-based circulating-microRNA isolation module, combine the module with
GAP1 to form GAP2, and use GAP2 to profile circulating MDCIS8 in lysed samples of 50-μL plasma from NSG
mice. The GAP2 is expected to concentrate the microRNAs by >5× and deliver sub-fM level sensitivity. (3) We
will demonstrate the feasibility of using this platform technology for diagnostic applications. We will use GAP2 to
quantify circulating MDCIS8, whose expression levels are indicative to pre-invasive breast cancer, in 50-μL
plasma samples from a user blinded cohort of the MIND murine model. The profiling result will be analyzed to
predict the progression of pre-invasive breast cancer whose rapid, inexpensive diagnosis remains a challenge.
The GAP2 prediction outcome will be combined with that based on surgical biopsy to establish the accuracy of
the technology for progression prediction. The expected prediction accuracy is >96%. If successful, the
technology will offer a new pathway to next-generation point-of-care genomic diagnostic/prognostic micro total
analysis systems that would be cheap enough and user friendly enough to be used in various clinical settings.

Public health relevance
PROJECT NARRATIVE The ultimate goal of the research, a highly integrated platform technology for multiplex, high-accuracy analysis of circulating microRNAs using a self-contained graphene-enabled device, holds great potential to promote point- of-care diagnosis/prognosis and public health in both short and long terms. The short-term outcome is to enhance disease diagnosis efficiency in time, cost, and sample consumption, and improve the prediction of pre-invasive diseases progression in a large population to enable immediate interventions to alleviate detrimental consequences. In the long run, through clinical trials and translational research on human subjects, the technology can be used for rapid and inexpensive nucleic-acid profiling in the development of customized disease treatment strategies to ultimately progress towards ending the disease.